Biocatalytic synthesis of complex medicinal small molecules informed by A.I. planning

The structural and stereochemical complexity of natural product analogs and some synthetic small molecules
can complicate the development of practical organic synthesis routes, leaving enzymatic, or ‘biocatalytic’, routes
as the primary source for drug discovery and production. Proposing these enzymatic routes requires expert
intuition and experience, but it is difficult for a single expert or a small group to be knowledgeable about the full
substrate scope of every class of enzymatic reactions. Further, the need for experts complicates the scaling of
the approach and hinders the development of automated, robotic platforms for enzymatic synthesis of small
molecules to accelerate drug discovery and scale up. Computer-Aided Synthesis Planning (CASP) tools in
enzyme chemistry use rule-based methods and machine learning to generalize known reactions to predict
enzymatic and chemo-enzymatic routes to a desired target molecule. Notwithstanding their success, three key
gaps remain that limit the practical use of these CASP tools for drug discovery and production. First, current
CASP tools still require substantial expert intervention to propose enzymatic routes to complex molecules starting
from simple building blocks. Second, enzymatic CASP tools have limited ability to synergistically use organic
and enzyme chemistry to propose hybrid chemo-enzymatic routes. For example, a preliminary tool published by
the PI and his co-authors is limited to proposing enzymatic drop-in replacements for organic steps. However, the
full effectiveness of biocatalytic retrosynthesis is realized when the introduction of one or more enzymatic steps
into a synthesis enables a major redesign of the synthesis route for drastically improved drug production (e.g.,
shorter routes). Third, the selection of enzymes to catalyze CASP proposed reactions relies heavily on the
enzymologists’ knowledge, and with thousands of plausible enzymatic reactions generated in a few minutes by
CASP tools, it would be impossible to rely on manual input for evaluating and recommending enzymes.
The PI’s research program will address these gaps by investigating three challenges: (i) Development
and experimental validation of a multi-step enzymatic synthesis planner that requires minimal expert intervention
(ii) Computational planning of de novo chemo-enzymatic synthesis pathways for complex medicinal compounds
and their analogs, and (iii) Enzyme sequence-function annotation using machine learning to recommend
enzymes for reactions proposed by CASP tools. The PI will curate high-quality databases and combine them
with state-of-the-art machine learning algorithms to predict experimentally testable enzymatic routes towards
medicinal small molecules. These algorithm-predicted routes will be reconstituted in vitro using purified enzymes
and simple building blocks to produce analytically pure samples of product molecules for mass spectrometry-
based characterization. The overall goal for the 5-year grant duration is to develop innovative computational
methods, bioinformatics tools, and experimental chemical-biology platforms to support the synthesis of complex
synthetic molecules and natural product analogs using enzyme reaction catalysis.

Public health relevance
Enzymes enable the synthesis of complex pharmaceutical agents because they catalyze selective chemical reactions under mild conditions. We will develop and test computational tools capable of proposing synthesis routes (or “recipes”) that primarily use enzyme catalysis to make complex pharmaceutical agents. These computational tools would identify ways to cost-efficiently manufacture complex pharmaceutical agents and would improve our ability to synthesize a diverse library of complex chemical compounds for drug discovery.